Genomics Facility Core

The Genomics Facility Core (GFC) provides the Southwest Environmental Health Sciences Center (SWEHSC)
investigators with high quality, cutting-edge, custom genomic services and data analyses, and consultation on
data analysis and training/education regarding genomic methods and bioinformatics. Overall, the objective of
the GFC is to provide SWEHSC members with guided, cost-efficient access to a full spectrum of genomic
technologies to facilitate novel and innovative research. To this end, the GFC was an early adopter of Next-
Generation Sequencing (NGS) technologies and functional genomics studies, and offers a broad range of
expertise to support the analysis of low-input and degraded materials as well as single-cell and other custom
enrichment techniques. To enhance the functional genetics research conducted by SWEHSC members, the
GFC provides numerous services such as deep sequencing, mutation detection, epigenetics, microbiome
analysis, gene expression profiling, and copy number analysis. Likewise, the GFC provides support on all
aspects of a study including sample isolation and quality control, all steps of the sample and data analysis, as
well as on data management and confirmation of the results. Finally, in addition to assisting with established
methodologies, the GFC develops and tests new technologies, platforms, and protocols in collaboration with the
SWEHSC investigators.